BLRD Research Career Scientist Award Application

My research investigates signal transduction, molecular structures, and pathophysiological actions of the
extracellular calcium-sensing receptor (CaSR) and its associated signaling molecules in the regulation of
mineral and skeletal homeostasis and more recently in the induction of brain diseases. During the current
research Career Scientist (RCS) award period, we uncovered the molecular actions of the CaSR in regulating
skeletal, parathyroid, and neuronal functions in both physiological and pathological contexts. During the next
RCS award period, my research will leverage those CaSR actions to explore the pharmaceutical potentials of
the receptor for treatments of the following aging-related diseases. (i) Osteoporosis and bone fracture. We
demonstrated previously the critical roles of the CaSR in prenatal skeletal development and postnatal bone
accrual by regulating parathyroid cell (PTC) functions and cell-autonomous activities of chondrocytes and
osteoblasts. Based on those studies, we developed a new regimen to enhance the FDA-approved parathyroid
hormone (PTH) therapy by co-targeting the CaSR in bone to treat osteoporosis without hypercalcemic side-
effects. Promising results from preclinical animal studies had led to a VA Merit Review award for a clinical trial
on VA patients with this new regimen. (ii) Neurodegeneration and dementia. My lab uncovered physical and
functional interactions of CaSR with the type B γ-amino butyric acid (GABA) receptor type 1 (GABA-B-R1),
which critically mediates inhibitory neurotransmission to prevent neuronal overactivity and subsequent
neurodegeneration. Based on our recent findings that CaSR overexpression is closely associated with neuronal
death in brains of mice subjected to ischemia (i.e., oxygen and nutrient deprivation) or traumatic brain injuries,
and mouse models of early-onset familial Alzheimer's Disease, we have begun to test the hypothesis that CaSR
overexpression/overactivity critically promotes neuronal death and brain degeneration in those diseases by
interfering with GABA-B-R1 signaling. This hypothesis is provisionally supported by our comprehensive in vivo
and in vitro pilot experiments. We will continue to pursue this line of research, aiming to develop pharmaceutical
regimens to treat neurodegeneration due to aging and other brain injuries. (iii) Primary hyperparathyroidism
(HPT). My group studied different genetically manipulated mouse models to delineate signaling mechanisms
mediating parathyroid cell functions, particularly the secretion of parathyroid hormone (PTH). We found that
mice with CaSR deficiency in their PTCs (PTCCaSR+/-) acquire HPT. Interestingly, in the background of
PTCCaSR+/- mice, concurrent removal of GABA-B-R1 or amyloid precursor protein (APP) in the same PTCs
prevents the development of HPT. We further found that Ab1-42, a cleaved product of APP, profoundly stimulates
PTH section, potentially by binding and activating CaSR/GABA-B-R1 heterodimer, indicating Ab1-42/GABA-B-
R1/CaSR signaling as a critical driver of PTH hypersecretion in primary HPT. I will continue this line of research
and test pharmacological regimens targeting CaSR/GABA-B-R1 heterodimer and reducing Ab1-42 access to
treat the disease. In addition to the above research activities, I will continue to serve as the Director of the
UCSF/SF-VAMC Skeletal Biology and Biomechanics Core to provide comprehensive skeletal phenotyping
services to more than 75 VA, NIH, and DOD projects and adopt the state-of-the-art technologies to enhance
multidisciplinary research in the SFVMAC and the greater UCSF community. This Core has been designated
by a new BLRD/CSRD FRACTURE CURB Collaborative Merit Review program to provide histomorphology and
molecular biology services to 8 Merit Review projects in 7 VA sites nationwide. I will also continue to disseminate
the floxed-CaSR and floxed-FGF23 mice that we generated and provide necessary reagents and intellectual
support to collaborators around the world to delineate tissue-specific actions of CaSR and FGF23 in skin,
cardiovascular, gastrointestinal, pulmonary, mammary glands, brain, immune system, and/or cancer research,
as our prior collaborative studies have uncovered diverse actions of CaSR and FGF23 in each of those systems.

Public health relevance
Our on-going research employs state-of-the-art technologies along with novel preclinical animal models to explore molecular and cellular mechanisms underlying the pathogeneses of several devastating diseases that afflict large populations of our VA patients, including osteoporosis, bone fracture, hyperparathyroidism, and neurodegeneration due to aging, brain injuries, or Alzheimer's Diseases. Such diseases greatly impact on the quality of life of our veterans and impose substantial socioeconomical burden on their families and the VA healthcare system. Successful completion of our highly translational research projects will not only advance our understanding of how those diseases develop, but also lead to timely therapies to prevent and/or treat the diseases. Indeed, one of the concepts that we developed to repurpose 2 FDA-approved drugs for a new combined therapy for osteoporosis are being tested clinically by our VA colleague to treat male VA osteoporosis patients. If validated, this new therapy could be soon available clinically.